Alliance NCORP Research Base - BIQSFP A211901 GY11 Supplement

PROJECT SUMMARY/ABSTRACT
The Alliance for Clinical Trials in Oncology (Alliance), one of five National Clinical Trials Network groups, serves
as the parent organization for the Alliance NCI Community Oncology Research Program (NCORP) Research
Base (Alliance NCORP). The Alliance NCORP conducts interventional and observational clinical and
translational research as well as database studies – all of which address important questions relevant to cancer
prevention, symptom control, and cancer care delivery. In addition, the Alliance NCORP conducts clinically
important quality of life studies that are embedded within cancer treatment trials. It places special emphasis on
minority, underserved and older patients at risk for or diagnosed with cancer, and on building strong collegial
relationships with NCORP Community sites and Minority/Underserved Community sites. The Alliance NCORP
committee membership includes rich representation from both community-based and academic medical centers,
as well as patient advocates, thus generating research results relevant to cancer patients across the United
States. The Alliance NCORP also emphasizes mentorship and training of junior investigators. Over this past
grant cycle, i.e., since August 2014, the Alliance NCORP has published over 240 manuscripts and abstracts.
This work has included practice-changing research in such areas as the prevention of chemotherapy-induced
nausea and vomiting, the prevention of skeletal-related events from osseous metastases, the management of
brain metastases, and the integration of patient-reported outcomes into cancer clinical trials. The Alliance
NCORP conducts translational research that requires the collection of tumor tissue, premalignant tissue
samples, blood, and other human biospecimens; and shares data and biospecimens for pooled analyses and
other scientific collaborations. These biospecimens create an invaluable repository for understanding clinical
observations from a mechanistic standpoint. The Alliance NCORP also collaborates broadly with other NCI-
funded investigators and consortia, as well as with investigators supported through non-NCI sources. This
practice-changing research and the scientific questions answered by the Alliance NCORP provide meaningful
and innovative contributions to clinical and translational oncology, which can be conducted only within a publicly-
funded research network.

Public health relevance
PROJECT NARRATIVE The Alliance NCI Community Oncology Research Program (NCORP) Research Base conducts research in cancer prevention, cancer symptom control, and cancer care delivery with a special emphasis on minority, underserved, and older patients and with a strong commitment to building collegial relationships with NCORP Community sites and Minority/Underserved Community sites. The Alliance NCORP seeks to continue its mission into the next grant cycle of generating practice-changing research that directly and favorably impacts the lives of cancer patients and those at risk for cancer.